Improving Diagnostic Accuracy for Acute Heart Failure

PROJECT SUMMARY/ABSTRACT
Acute heart failure (HF) is highly morbid, lethal, and costly. It is a difficult diagnosis to make given its symptoms
and signs overlap with other cardiac and non-cardiac conditions. In the emergency department (ED),
misdiagnosis of acute HF is common and associated with adverse outcomes. Biomarker testing can facilitate
accurate diagnosis; however, natriuretic peptides (NP) are the only guideline recommend biomarker of HF for
diagnostic testing, and are better for ruling-out, rather than ruling-in, acute HF. Even with NP testing, in
contemporary clinical practice misdiagnosis of acute HF still occurs in 10 to 45% of patients presenting to the
ED with dyspnea. Clinical prediction models including multiple biomarkers hold promise for improving
diagnostic accuracy. The few prior studies investigating a multiple biomarker approach for diagnosing acute HF
were limited by constraint to highly correlated markers from known biologic pathways, relatively small sample
sizes, lack of inclusion of all a priori selected biomarkers into a single model, and absence of validation
cohorts. Our study design addresses these limitations. Recent advances in “omics” enable novel biomarker
discovery on a larger scale and investigations less “biased” by existing knowledge. Thus, our overarching
hypothesis is a multi-marker model incorporating novel proteins discovered with plasma proteomics improves
diagnostic accuracy for acute HF. In preliminary work, we performed a proof of concept study utilizing plasma
proteomics to discover a multi-marker panel of 21 biomarkers which improved diagnostic accuracy for acute
HF beyond current clinical practice using clinical data and NP levels. Our promising preliminary data motivate
broader discovery in a larger sample size with subsequent derivation and validation of a multi-marker model for
diagnosing acute HF in independent samples of adequate size. Our specific aims are to: 1) expand the
discovery cohort and refine the multi-marker panel of 21 biomarkers to improve diagnostic accuracy for acute
HF, 2) derive a model for diagnosing acute HF incorporating the 21-biomarker panel, 3) test performance of
the multi-marker model in a prospective validation cohort, and 4) assess the incremental value of the multi-
marker model for diagnosing acute HF. In aim 1, existing plasma samples from 989 patients will be used to
assay 925 proteins to discover a smaller set of novel biomarkers most strongly associated with an adjudicated
acute HF diagnosis. In aim 2, we will utilize an existing prospective observational cohort, EMROC-AHF, to
derive the multi-marker model in 1,000 patients who presented to the ED with acute dyspnea. In aim 3, from
four EDs in Detroit, MI and Nashville, TN we will prospectively recruit a new sample of 1,000 patients
presenting with acute dyspnea and adjudicate the presence of acute HF by cardiologist panel review. In aim 4,
we will compare our multi-marker model against the current clinical approach for diagnosing acute HF using
the cohorts for Aims 2 and 3. Given the burden of HF, the frequency of inaccurate diagnosis and its adverse
consequences, we will address a significant unmet need by improving diagnostic accuracy for acute HF.

Public health relevance
PROJECT NARRATIVE Acute heart failure is a common reason for emergency department visits and hospitalization, but the diagnosis can be challenging because of non-specific symptoms and signs. The current diagnostic approach to acute heart failure has modest accuracy, leading to delayed diagnosis and treatment, which associate with worse prognosis. Our prior work suggests diagnostic accuracy can be improved with the addition of multiple circulating biomarkers discovered through proteomics, and herein we propose to derive and validate a multi- marker model to improve diagnostic accuracy for acute heart failure in the emergency department.